Cone Opsin-Ligand Interactions and Photoreceptor Health

The broad objective of this project is to prevent cone photoreceptors from degenerating. In a disease such as Leber Congenital Amaurosis (LCA), the levels of the native chromophore, ii-cis retinal, for visual pigments is absent or highly reduced. Vision is impaired not only because of a lack of visual pigment generation but also because cone photoreceptors are lost. In a mouse models for LCA, cone visual pigment proteins (opsins) are highly mislocalized and cone cells subsequently die. Damage seems to be most severe with blue cones. This pattern appears to parallel the pathogensis of LCA. Treating these mice with ii-cis retinal at an early age in the dark preserves healthier cones, suggesting that opsin's binding of ii-cis retinal is an important step in preventing cone death. A drawback to 11- cis retinal itself as a therapeutic agent is that it is destroyed once it combines with the opsin and exposed to light. The working hypothesis for this proposal is that in the absence of the native chromophore, chemical compounds that can mimic the effects that ii-cis retinal has on the cone opsins will also mimic the cellular effects on the cone photoreceptors. The main advantage of such compounds is that the treatment period will not require constant dark conditions. At the molecular level, cone opsins are constitutively active, and ii-cis retinal deactivates the opsins. A library of compounds that are analogs of ii-cis retinal will be tested for their effectiveness in turning off human cone opsins as judged by their abilities to activate transducin. Compounds that effectively deactivate the opsins will then be tested in isolated cone photoreceptor cells to ensure they are not toxic to cells and they are able to deactivate cone opsins inside a living cell. Compounds found to meet these criteria will be tested in 2 mouse models of LCA to determine if they can prevent the rapid degeneration of cone photoreceptor cells as judged by fluorescence microscopy and electroretinography. The ability to preserve the viability of cone photoreceptor celis in those afflicted with LCA will be a critical step to restoring visual acuity.

Public health relevance
Project Narrative Everyday vision is highly dependent on the use of cones which contain light-sensitive visual pigments consisting of a protein component called opsin and a vitamin A derivative called 11-cis retinal. Leber Congenital Amaurosis (LCA) is an early onset eye disease where not only is synthesis of 11-cis retinal compromised such that pigments are not formed but also the cone cells degenerate rapidly after which restoration of 11-cis retinal is of no help. This proposal aims to develop chemical compounds that will prevent cones from dying in LCA.